Alzheimer's Disease Sequencing Project Phenotype Harmonization Consortium

Abstract
In response to PAR-20-099 “Harmonization of Alzheimer’s Disease and Related Dementias
(AD/RD) Genetic, Epidemiologic, and Clinical Data to Enhance Therapeutic Target Discovery”,
we have assembled a multidisciplinary team that includes experts in neuroimaging,
neuropsychology, fluid biomarkers, neuropathology, and vascular contributions to ADRD to work
in close partnership with the NIH and the Alzheimer’s Disease Sequencing Project (ADSP). Our
ADSP Phenotype Harmonization Consortium, or “ADSP-PHC”, seeks to work in coordination
with existing ADSP workgroups and initiatives to (1) streamline access to endophenotype data,
(2) provide high quality endophenotype harmonization across multiple research domains, and
(3) provide comprehensive documentation of both data availability and harmonization
procedures. This project includes two coordinating centers, three cores, and eight domain-
specific harmonization teams led by world-renowned experts in their fields. While our efforts will
focus on data access, documentation, and harmonization, we will work closely with other ADSP
workgroups and other large-scale harmonization efforts to maximize the impact and align with
NIH priorities. In particular, we will focus harmonization on ADRD-related endophenotypes,
including cognitive scores derived from detailed neuropsychological assessments, measures of
neuropathology measured both ex vivo (neuropathological assessment at autopsy) and in vivo
(fluid biomarkers and positron emission tomography biomarkers), concomitant pathways of
injury (vascular risk factors and vascular brain injury), and measures of neurodegeneration
focusing on both white (diffusion-weighted MRI) and grey matter (T1-weighted MRI). The
proposed harmonization effort will provide an unprecedented opportunity to disentangle the
genetic architecture of individual biological contributors to ADRD risk and progression. The
harmonized data, protocols, and educational tools developed by the ADSP-PHC will transform
the ADRD landscape, accelerate discovery, and facilitate the application of emerging big data
analytic approaches leveraging machine learning and artificial intelligence.

Public health relevance
NARRATIVE The growing availability of endophenotypic data in cohort studies of Alzheimer’s disease (AD) provides an exciting opportunity to further characterize the genetic architecture of this devastating disease. However, there is a pressing need to develop and apply advanced harmonization approaches to align AD-related endophenotypes across cohorts. The goal of this coordinated national initiative – the AD Sequencing Project Phenotype Harmonization Consortium, or “ADSP-PHC” - is to provide a centralized database of robust endophenotypes for large-scale genomic analyses that will accelerate the identification of novel targets for therapeutic intervention in AD.